Prevention of alpha-synuclein deSUMOylation as a Parkinson's therapeutic target

A form of post-translational modifications (PTM), SUMOylation of target proteins has been
implicated in Parkinson’s disease pathology (10), however, it is still debatable as to whether
SUMOylation contributes to the disease or is a protective mechanism (9). Our recent publication
using mouse models suggest that the overexpression of SUMO conjugase, Ubc9 protects
dopaminergic axon tips in the striatum and cell bodies in the SN from the known PD-inducing
reagent (MPTP) that results in Parkinsonian symptoms (Fig 1) (12). In addition, the MPTP
treatment results in decreased SUMOylation of α-synuclein in mouse striatum (Fig 2), suggesting
that MPTP-induced toxicity stimulates the deSUMO enzyme, SENP for removing SUMOs from α-synuclein, which may be associated with dopaminergic neuronal loss in the SN. Our recent results
support that SENPs can be regulatory targets to prevent the deSUMOylation process that may
be a part of protein aggregation and neuronal death pathway. Particularly, we identified
consistently in N27 cells, mouse models and human Parkinson’s disease patients SNpc that
SENP1 among known 6-7 mammalian SENPs, was significantly upregulated by MPP+ or the
preformed fibrils (PFF) of α-synuclein-mediated toxicity (Figs 3,4). However, the MPTP induced
toxicity does not recapitulate the typical protein aggregation-mediated PD pathology. Therefore,
we adopt the recently established method using the preformed fibril (PFF) of α-synuclein for
mimicking protein aggregation-mediated PD pathology. We test the hypothesis that blocking
deSUMOylating enzyme, SENP1 prevents PFF-mediated toxicity in dopaminergic neurons.
Using SENP1 RNAi, dominant negative, or chemical inhibitors, we will assess the target validation
of SENP1 inhibition to enhance protein stability/solubility and to prevent PFF-induced protein mis-folding and aggregation. In addition, we will also verify that SENP1 expression in the SN from
additional human PD midbrains was significantly higher than that in age- and gender-matched
healthy controls using additional 10 samples per group. In parallel, we will assess the proteomics
shifts in SUMOylation and SENPs in PFF-injected mouse brains using mass spectrometry. This
study will provide new strategies for protecting dopaminergic neurons from protein aggregation-mediated toxicity that leads to Parkinson’s disease. Our potential outcome will result in meaningful
publications and reveal novel target validation, as well as offering great opportunities for
underrepresented (under)graduate students at an HBCU to learn essential scientific techniques
and unique approaches from leading scientific groups.

Public health relevance
Parkinson’s disease (PD) is the most common motor neurodegenerative disease, affecting almost one million citizens in the United States alone. The disorder is primarily characterized by the selective loss of dopaminergic neurons in the Substantia Nigra pars compacta (SNpc) and the formation of intraneuronal inclusions called “Lewy bodies,” which contain alpha-synuclein as their major protein component (1,2). Although understanding the neuropathological mechanisms of PD remains elusive, it has been reported that impaired proteasomal function can induce enhanced alpha-synuclein aggregates, which include SUMOylated form. In the halo of Lewy bodies, SUMO1 (Small Ubiquitin-like Modifier 1) co-localizes with alpha-synuclein in human PD brains (10). This suggests that SUMOylation of alpha-synuclein and another PD-related protein, Leucine-rich repeat kinase 2 (LRRK2), can be potential targets to regulate the protein stability and function in dopaminergic neurons. We propose to investigate the pan-SUMOylation or preventing deSUMOylation for determining the role of SUMOylation in modulating protein stability and protecting dopaminergic neurons in the striatum and SN from the preformed fibrils (PFF) of alpha-synuclein induced toxicities in PD models (14,15). Our recent publication demonstrated that Ubc9-mediated SUMOylation enables dopaminergic neurons in the striatum and SNpc to be more resistant to MPTP-induced toxicity in mice and delays the protein degradation of dopamine transporter (DAT) and alpha-synuclen (12,13). In addition, both proteins are constitutively SUMOylated in mouse striatum, and chronic MPTP injections removed the SUMO1 conjugation from alpha-synuclein. These results suggest that Ubc9-mediated SUMOylation in dopaminergic neurons can be neuroprotective against PFF- induced oxidative stress, and SUMO proteases, SENPs can be stimulated by MPTP (or MPP+)- induced oxidative stress and in human PD midbrains (Figs 1&4). Therefore, SUMOylation of autosomal dominant PD-inducing proteins such as alpha-synuclein, can be a novel regulatory target to enhance protein stability/half-life and function in dopaminergic neurons. Our goal of this study is to identify the role of SUMOylation and to verify the feasibility of SENP inhibition in vivo and ex vivo for protecting dopaminergic synaptic connections and cell bodies from PFF-induced toxicities and regulating PD-related proteins’ stability. Thereby, this study can provide insights into neuroprotective mechanisms of SUMOylation to regulate protein solubility/stability. SUMOylation and deSUMOylation can be a novel regulatory target to halt or slow alpha-synuclein-mediated protein aggregation and prevent dopaminergic neuronal loss in PD pathology.